Lectin Resistant Tumor Cells and Functional Glycomics

Project Summary
The long term goal of this program is to understand how glycosylation regulates biological events,
such as cell differentiation and growth control, in development and cancer. We showed
previously that MGAT1, the GlcNAc-­transferase that initiates complex N-­glycan synthesis, is
essential for spermatogenesis. Recently, we determined that conditional loss of MGAT1 in
spermatogonia leads to premature upregulation of genes normally expressed later in
spermatogenesis, and to reduced ERK1/2 signaling that we hypothesize is due, at least in part,
to the loss of complex N-­glycans on the MGAT1 target basigin. Global deletion of basigin gives a
similar block in spermatogenesis, and loss of complex glycans on basigin leads to reduced
ERK1/2 signaling. We will test the hypothesis that the N-­glycans on basigin promote ERK1/2
signaling and their loss in after MGAT1 removal leads to defective spermatogenesis. We will
determine if complex N-­glycans mediate Sertoli-­spermatid interactions important for
spermatogenesis. If so, we know that hybrid N-­glycans do not support spermatogenesis, and will
determine if biantennary, complex N-­glycans suffice. Since MGAT1 is pivotal to the generation of
complex N-­glycans, and the absence of N-­glycans is desirable in a large variety of different
contexts, including to inhibit cancer progression, it has long been desirable to have a small
molecule inhibitor of MGAT1. We believe that the time is ripe to succeed in this endeavor. We
have shown that GnT1IP, a physiological inhibitor of MGAT1, forms heteromers with MGAT1 in
the Golgi, and identified the C-­terminal two amino acids in GnT1IP as separately necessary to
inhibit MGAT1. We will determine 3D structures of MGAT1, GNT1IP and MGAT1/GnT1IP
heterodimers, with and without these mutations, to determine the mechanism of inhibition. We
will use this information to develop a TAT-­peptide inhibitor that will work in the Golgi. Finally, we
will isolate small molecule inhibitor(s) specific for MGAT1 by high throughput screening of
chemical libraries, and by in silico docking of 14 million compounds to available crystal structures
of MGAT1 versus related glycosyltransferases MGAT2 and POMGNT1. A small molecule
inhibitor of MGAT1 will be extremely valuable in many areas of research, for glycosylation
engineering of biotherapeutics, as a potential male contraceptive, and for inhibiting cancer
progression.

Public health relevance
Public Heath Statement The addition of sugars (glycans) to proteins to make glycoproteins is common. Glycans profoundly affect the functions of glycoproteins and defective synthesis leads to numerous human diseases, including cancer. We will determine why a pivotal glycosylation enzyme is essential for spermatogenesis in mammals, and isolate small molecule inhibitor(s) of this enzyme for use in research and biotechnology and as a therapeutic to block sperm production, or to block the progression of cancer.